Outreach Core

INFORMATION DISSEMINATION CORE (Cyders & Zapolski, Co-PIs)
Project Summary/Abstract
Reducing the prevalence of Alcohol Use Disorder (AUD) requires an approach in which intervention
and education are widely accessible and on a continuum from the beginning stages of use (e.g., prevention) to
problematic, risky, and disorder-levels of use (e.g., intervention). Stakeholders in AUD prevention and care
include patients, family members, health care providers, community institutions (e.g., schools, hospitals),
lawmakers, and the general community. The theme of this Indiana Alcohol Research Center (IARC) is to
investigate factors that contribute to risky, binge and high-intensity drinking behaviors (BHID). The long-term
goal of this Core is to collaborate with our community partners to improve outcomes for AUD across the state
of Indiana. Our work is driven by the needs of these partners and will be guided by a community-based
participatory research (CBPR) framework. The objective of this Core is to serve as a bridge for the strong
expertise and empirical science conducted in our IARC and engagement with our community – with the
ultimate goal of increasing public knowledge about the scientific underpinnings of AUD, especially in under-
resourced communities, and improving AUD outcomes. Specific Aim 1: Disseminate findings on adolescent
alcohol use and AUD outcomes as well as prevention programming material to school partners to increase
public knowledge of adolescent alcohol use and AUD and increase access to adolescent substance use
prevention programming, particularly among underserved youth and communities. We plan to engage with our
school partners by providing educational material on the prevalence, risk factors for and consequences of
adolescent alcohol use and BHID for school administration, teachers, and school mental health providers (e.g.,
school nurses and guidance counselors). We have also created dissemination material fora school-based
substance use prevention program and plan to further engage with our school partners by training
professionals within school settings to deliver the prevention program across the state, particularly in
underserved communities. Specific Aim 2: Serve as an educative and advisory body for our community
partners in a way that allows for the broadest reaching impact on AUD services and policy in the state of
Indiana. We plan to engage with our community by creating 1) an AUD training program for healthcare
providers; 2) expert services for educational, community, and client advocacy agencies, and 3) an amplified
website presence and accessibility for ongoing IARC experts and resources. Through these two aims, we seek
to improve community education on the science of AUD. The positive impact of our proposed work will be
in reducing prevalence of and improving outcomes for youth with AUD throughout the state of Indiana by
expanding access to AUD science programming, and by helping inform science-based policy, provider
education, and community awareness. We also seek to enhance our IARC’s relationships with community
partners across Indiana.